AdvanceBox System with Networked, Monitored, and Mapped Rescue Supply Containers (Phase I)

PROJECT SUMMARY
Preventable deaths in children are on the rise. Adolescent deaths by drug overdose more than doubled
between 2019 and 2021 (with over 90% of deaths involving opioids), and school shootings have more than
doubled in the past 5 years. The number of pediatric deaths from opioid overdose and penetrating trauma can be
reduced by timely use of simple-to-use rescue tools if they are immediately accessible: naloxone is an effective
antidote for opioid overdose that can restore consciousness and breathing, and tourniquets and hemostatic
dressings can stem life-threatening bleeding and avert hemorrhagic shock. Whereas automated external
defibrillators (AEDs) for out-of-hospital cardiac arrest (OHCA) are widespread (3 million in the US) and accessible
in schools, naloxone and hemorrhage control kits rarely are publicly accessible in schools and other institutions
caring for adolescents. This lack of preparedness means that preventable adolescent deaths continue to accrue
unnecessarily. The AdvanceBox system publicly positions rescue tools and pairs them with technology,
instructions, and links to training resources to ensure that the tools are reliably monitored, maintained,
discoverable, and effectively used.
The AdvanceBox cellular-connected modular storage system houses simple lifesaving tools with just-in-time
rescue infographics / instructions for opioid overdose and traumatic hemorrhage, provides Web links to training
videos and established learn-ahead resources, enables remote viewing and container monitoring, communicates
system status, sends text/email notifications when opened, maps installations so 9-1-1 dispatchers can direct
callers to nearby rescue tools, and facilitates rescue tool re-supply. In this NIH SBIR Phase I program, Nimbus
Research Laboratory (NRL) will accomplish the following Aims to establish the utility and value of Design
Validation Testing (DVT) prototypes and to support development of a market-ready product that can be
manufactured at scale, sold, and broadly deployed:
- Aim 1: Design, build, deploy, and field-test AdvanceBox Design Validation Testing (DVT) prototypes
- Aim 2: Deliver just-in-time instructions and promote learn-ahead training for staff and bystander rescuers
- Aim 3: Explore fit of AdvanceBox innovations with institutional needs and determine best applications
The proposed SBIR Phase 1 work consists of system design, construction, and field testing with health
communication and health technology consultant experts to demonstrate feasibility and utility while preparing for
economic production at scale; development, packaging, and promotion of instructional and learn-ahead materials
for access via AdvanceBox units; and visiting and interviewing personnel at schools and organizations that care
for adolescents. NRL strives to deliver an integrated system of rescue tools, information, communications,
mapping, and supply management that helps educational and youth development institutions prepare for some of
the greatest risks that adolescents currently face. SBIR Phase II work will focus on preparing a reliable, user-
friendly, and commercially viable system product that can be nationally implemented at schools, with a longer-
term goal of addressing unmet rescue needs in high risk populations and additional age groups.

Public health relevance
PROJECT NARRATIVE Too many people in the US continue to die from drug overdose and penetrating trauma, and these crises are increasingly impacting adolescents. Through this NIH SBIR program, Nimbus Research Laboratory will develop, test, and implement a multi-compartment “AdvanceBox” smart storage system that provides additional rescue tools for life-threatening medical emergencies in public places such as schools so that bystanders and facility staff have rapid access to easy-to-use tools that can save lives. The AdvanceBox containers will additionally feature just-in-time rescue tool use infographics / instructions, Web links to learn- ahead videos, Web-enabled connections to layperson resuscitation training resources; 24/7/365 remote monitoring with imaging sensors, reliable networking, and electronic notifications that alert owners and managers when a container is opened or a rescue tool is used / expired; sharing of tool location and status to 9-1-1 dispatchers; and facilitated supply re-stocking.